Stereoselective Nickel-Catalyzed Coupling and Cascade Reactions

Project Summary/Abstract
This proposal outlines the development of new chemical methods for cross-coupling
reactions for formation of strained rings and in domino reactions. The objectives of this
project are to generate new strategies for stereoselective coupling reactions, including
stereospecific and stereoconvergent reactions. Reactions will be triggered such that
typically sluggish functional groups, including alkyl alcohol derivatives, will participate.
The development of these reactions will directly impact the development of new
pharmaceutical agents by providing new strategies for their preparation.

Public health relevance
Project Narrative The development of new chemical methods for organic synthesis is essential in the preparation of natural products and other bioactive molecules for preliminary biological studies, clinical trials, and production for market. Despite the advanced state of synthetic chemistry serious challenges remain. This proposal describes the development of new chemical reactions that will address one of these challenges, cross-electrophile coupling and cascade reactions that form tertiary stereogenic centers embedded in cyclopropanes and ring systems.